Leveraging Multi-Modal AI for Selective Use of Ultrasound in Breast Cancer Screening

Project Summary
Supplemental breast screening ultrasound is recommended for women with dense breasts, accounting for nearly
half of U.S. women over age 40. While breast ultrasound improves cancer detection rates, its cost-effectiveness
remains low for women at average risk of breast cancer, with a cost-effectiveness ratio of $728,000 per quality-
adjusted life year (QALY) gained. This limited efficiency is driven by high false-positive rates in breast ultrasound
interpretation, leading to unnecessary diagnostic workups and biopsies, and by one-size-fits-all guidelines that
recommend supplemental ultrasound for all women with dense breasts. This proposal aims to improve the
diagnostic accuracy and cost-effectiveness of breast cancer screening by building an AI system to determine
the necessity of supplemental screening ultrasound. Our core hypothesis is that in a substantial portion of the
screening population, it is possible to forgo currently guideline-recommended supplemental ultrasounds without
impacting diagnostic accuracy. To verify this hypothesis, we propose the following aims. First, we will build a
multi-modal deep neural network, Multi-Modal Diagnoser (MMD), that integrates current and prior
mammographic and ultrasound imaging data to improve detection of breast cancer. To train MMD, we will
assemble a substantial dataset of over 2.12 million exams (420,000 patients) from our institution, as well as two
external datasets from other institutions for independent evaluation. MMD will serve as the foundation for our
second model, the Ultrasound Benefit Predictor (UBP). UBP will utilize screening mammography images to
determine the necessity of supplemental ultrasound for women with dense breasts through an interpretability
mechanism that highlights specific mammographic regions where ultrasound could add diagnostic value. Finally,
we will critically assess these two elements of our AI system through a retrospective study, examining their
impact on radiologists' performance and cost-effectiveness through the lens of patients’ QALY. This project
seeks to pioneer the integration of AI in breast cancer screening, leading to more personalized patient care and
optimized healthcare resource allocation.

Public health relevance
Project Narrative This project addresses a critical public health concern: the diagnostic accuracy and efficiency of mammographic and sonographic screening of breast cancer. The proposed framework will improve cancer detection by combining these two imaging modalities using deep neural networks; in addition, it will decrease unnecessary ultrasound exams and subsequent additional imaging and procedures by automatically determining the necessity for screening ultrasound in select women with dense breasts. Our innovations have the potential to enhance patient care, optimize healthcare resource utilization, and ultimately improve clinical outcomes in breast cancer, an increasingly prevalent disease worldwide.